Longitudinal Investigation of TMS as a Tool to Improve Alcohol Treatment Outcomes

Project Summary
The primary purpose of this administrative supplement to AA027705 is to cover the costs associated with data
sharing as required by the NIAAA. The multi-PIs of this project took over in November of 2022 when the
original project PI left Wake Forest University School of Medicine. As part of this project transfer, it became
clear that study data was not actively being submitted to the National Institute on Alcohol Abuse and
Alcoholism Data Archive (NIAAADA). Unfortunately, when the original grant proposal was submitted, funds
were not requested to cover the costs associated with data submission. Based on all the information we have
gathered about the submission process, our experience with the data from this project, the fact that none of our
data fields are in the NDA format, and estimates from NDA Data Submission Cost Estimation Tool, we have
determined the costs that will be incurred. There are no changes in the study aims as part of this administrative
supplement. The project remains a double-blind placebo controlled, randomized study to evaluate the relative
efficacy of 2 potential TBS treatment strategies for AUD. Specifically, participants will be randomized to receive
real or sham TBS delivered to the ventral medial prefrontal cortex (vmPFC), or dorsolateral prefrontal cortex
(dlPFC). The primary outcome measures remain the percent days abstinent and the percentage of heavy
drinking days. Secondary outcomes measures include changes in craving and change in brain response to
alcohol cues will be measured using functional magnetic resonance imaging. The requested budget will cover
the cost of submission of all the data relevant to the primary and secondary outcomes of the study from the
planned 160 study participants.

Public health relevance
Project Narrative The long term goal of our multidisciplinary research team is to develop an evidence-based brain stimulation treatment protocol which will improve AUD treatment outcomes.